Emory Alzheimer's Disease Research Center

SUMMARY/ABSTRACT: OVERALL
The Goizueta Alzheimer’s Disease Research Center (ADRC) at Emory University provides Georgia and the
region with comprehensive clinical, research, and educational programs. This application outlines our success
in building an environment that encourages and supports innovative projects with a central theme of discovery
and translation of new biomarkers and pathogenic mechanisms to enable early identification, intervention, and
ultimately prevention of AD and related disorders. Given the well documented disparities in clinical research
participation and burden of disease for AD in the African American community, the Goizueta ADRC dedicates
effort and resources to help better understand and address inter-individual differences in AD and ADRD,
ranging from ethno-racial factors to individual differences in genetic and protein variation. We benefit from
generous institutional support from Emory, one of the nation’s fastest growing research academic medical
centers, the generous Atlanta community, and a large and highly collaborative interdisciplinary team of more
than 100 faculty across Emory and local institutions. Our cores work in a concerted manner to effectively
recruit, evaluate, and engage a diverse cohort of participants who actively take part in a wide variety of
research studies. The addition of a Minority Engagement Core helps to further engage special populations,
most notably the African American community, to help the Outreach, Recruitment and Engagement Core and
Clinical Core with an ambitious goal of 50% African American participation in the UDS cohort. Our Biomarker
Core provides state-of-the-art genetic, proteomic, and brain imaging analyses, complemented by an extensive
biospecimen repository of well-characterized blood, CSF, and DNA samples, and a large bank of well-
characterized postmortem brains and spinal cords in the Neuropathology Core. These valuable resources will
continue to be distributed widely for a variety of approved studies, including research Developmental Projects
and in support of local and national collaborations. Generous institutional and philanthropic support is used to
seed a much larger base of innovative research. The ADRC educational programs reach a broad audience of
trainees, researchers, health care professionals, and the public. New to us with this application, the Research
Education Component will help formalize our longstanding dedication to the cultivation of the next generation
of scientists. With a strong commitment to diversity and inclusiveness, our program benefits from the
engagement of a large and multidisciplinary core of training faculty mentors from institutions throughout the
greater Atlanta area. Collectively, the ADRC is poised to continue to make important contributions to the
national strategy for AD treatment and prevention.

Public health relevance
PROJECT NARRATIVE: OVERALL The Goizueta ADRC at Emory continues to grow dramatically over each 5-year cycle and is submitting this application to seek funding for years 16-20 of our center. The ADRC contributes to the NIH/NIA-funded network and plays a critical role in the coordinated response to the growing public health threat from Alzheimer’s disease (AD). Emory’s participation in the network fosters research to understand the causes, and investigate novel targets and interventions that could lead to more effective treatments and prevention, and improve the treatment of affected individuals with AD and related dementias and the well-being of their family caregivers.